RNA-based PROTACs Targeting HIV-1

Project Summary/Abstract
A broadly applicable cure for HIV infection remains elusive, in part because many of the viral and cellular proteins
that could be targeted in cure strategies are neither enzymes nor receptors, poorly suited to conventional
approaches to drug discovery. The proposed research will optimize a system for developing molecules that direct
the degradation of these “undruggable” target proteins. Such an approach could be used to target proteins that
are critical for immune evasion by HIV, such as the accessory proteins, or cellular proteins critical for the
maintenance of viral latency, a critical barrier to viral eradication.
This approach involves the innovative combination of PROteolysis-TArgeting Chimeras (PROTACs), bi-
functional molecules that recruit target proteins to an E3 ubiquitin ligase to trigger their degradation, with RNA
aptamers, short RNAs that can be selected to bind a protein target regardless of whether the protein is known
to bind RNA in vivo. The developed RNA-based PROTACs will, with the RNA aptamer end, bind their target
proteins, and, with the PROTAC end, recruit cellular machinery that ubiquitinates the target protein, thereby
directing its destruction. Unlike typical drug targeting, the RNA-PROTAC need not fit into a particular site on the
protein or directly inhibit its activity to function in this system. Methods to identify novel RNAs with specific protein-
binding activity are well-described. High-affinity single-stranded short RNAs can be isolated in vitro from large
libraries by a process called Systematic Evolution of Ligands by EXponential enrichment (SELEX), yielding low
or sub-nanomolar protein ligands.
In this proof-of-concept study, two HIV proteins that bind specifically to known RNA sequences, Rev and Tat,
will be employed as prototype targets. First, their known RNA targets will be conjugated to PROTACs using
CLICK chemistry, delivered to cells and then tested for target degradation to optimize and validate the methods
to link targeting RNAs to small molecules that recruit E3 ligases. We will also use SELEX to identify novel
aptamers as the target-binding moiety, evolving modified RNAs for optimal ligand binding. The conjugation of
the RNA aptamer to the PROTAC by CLICK chemistry requires the incorporation of modified ribonucleotides,
which, when present in different ratios could affect target binding. The advantage of the proposed procedure is
that the SELEX process will be performed with variable amounts of modified ribonucleotides to optimize targeting
of the proteins of interest. In the case of our prototype targets, Rev and Tat, the sequences of the optimal modified
RNA aptamers determined by SELEX may be different from their known RNA targets. The proposed experiments
will develop a new strategy for drug design targeting HIV. Future studies will target other “undruggable” viral and
cellular targets that could sensitize HIV-infected cells to immune surveillance and contribute to the reversal of
viral latency.

Public health relevance
Project Narrative Many viral and cellular targets for HIV cure strategies are neither enzymes nor receptors, making them less amenable to typical drug discovery mechanisms. The proposed research develops a method to degrade these “undruggable” targets by generating PROteolysis TArgeting Chimeras (PROTACs) that direct the cell's machinery to mark the protein for destruction. The crucial innovation of this approach is to link these PROTACs to short RNAs, called aptamers, which have been selected through an iterative screening process to specifically bind the HIV or cellular target protein and eliminate it.